Characterization of lung interstitial neutrophils

Project Summary
Neutrophils are major players in the innate immune system, known for their role in fighting infections by
engulfing and destroying invading pathogens, including those in the lungs. Neutrophil heterogeneity is a key
component in innate immune regulation. Distinct mature neutrophil subpopulations, defined by their signature
gene expression profiles, phenotypes, behaviors, and functional states, exist even prior to encountering
pathogens. Understanding the unique features and origins of these functional subpopulations will enable the
effective and safe manipulation of their specific functions for personalized medicine. The objective of this
proposed project is to investigate the origin and characterize the functional state of the lung interstitial
neutrophil (LIN) subset. Preliminary scRNA-Seq analysis revealed a tightly regulated neutrophil
reprogramming trajectory during lung infection and inflammation, based on gene expression patterns. The
preliminary studies identified the functional heterogeneity of neutrophils across three different lung
compartments: the vasculature, the interstitium, and the alveoli, and discovered that neutrophils lodged in the
interstitium for an extended period before migrating to the alveoli. Based on these findings, it was
hypothesized that transcriptional reprogramming leads to the formation of a specialized LIN subset defined by
its unique gene expression profile. These neutrophils are highly specialized, with significant bactericidal
activity, making the lung interstitium a primary site for bacterial elimination. Accordingly, expanding the LIN
population could be a viable therapeutic strategy for enhancing neutrophil-mediated host defense, while
potentially detrimental in sterile inflammation-induced acute lung injury. To advance the understanding of the
function, fate, pathophysiological role, and origin of LINs and explore their therapeutic potential, three specific
aims will be investigated: Aim 1 will characterize the functions and fate of LINs. In addition, neutrophil-
mediated bacterial killing in the interstitium will be visualized and confirmed by fluorescent imaging. Aim 2 will
elucidate the pathophysiological role of LINs in lung infection and inflammation. The LIN population will be
expanded by inhibiting CCR2-mediated neutrophil transepithelial migration, and its effect on host bactericidal
activity and lung injury will be tested in a neutropenia-related bacterial pneumonia model and an acid
aspiration-induced acute lung injury (AA-ALI) model. Aim 3 will further investigate the microenvironment-
induced transcriptional reprogramming that confers specialized functions to LINs. Additional scRNA-Seq
analyses will be performed to gain a deeper understanding of neutrophil reprogramming in the interstitium and
to reveal potential temporal and stimulus-specific reprogramming schemes. Together, the results from this
study will establish LINs as a specialized neutrophil subpopulation with unique phenotype and function, and as
a novel therapeutic target for treating lung infections and inflammation.

Public health relevance
Project Narrative Disentangling the beneficial and harmful activities of neutrophils has proven exceptionally difficult, and for this reason there remains to date no single human drug that either targets neutrophils or specifically leverages their unique biology for therapeutic purposes. The experiments proposed in this study will not only enhance our understanding of the unique features and origin of the specialized lung interstitial neutrophil (LIN) subset but will also pave the way for novel therapeutic approaches targeting these cells in treating inflammatory and infectious diseases, particularly neutropenia-related pneumonia and acid aspiration-induced acute lung injury.